Dissecting the Mechanisms of Pioneer Factor Facilitated Chromatin Opening

Project Summary
Nucleosomes cover most of the eukaryotic genome and present a barrier for the competent binding of many
regulatory proteins that control gene expression. A special set of transcription factors called pioneer factors can
bind their target sites on nucleosomal DNA, loosen chromatin, and promote the activity of other chromatin factors
and enzymes, leading to nucleosome repositioning and gene activation. Sox2 and Oct4 are pioneer factors that
orchestrate changes in cell fate during embryogenesis and adult neurogenesis and are major players in the
reprogramming of somatic cells into a pluripotent state. Mutation and deficiency in these proteins are linked to
neurological disorders, while their enrichment is tied to cancer. Despite ample studies, little is known about how
to Sox2, Oct4 and other pioneer factors exert their pioneering activity at the molecular level. Our goal is to
address key unresolved questions about how Sox2 and Oct4 engage with nucleosomes in distinct binding modes
and alter the structure and dynamics of nucleosomes, and how these changes affect the downstream action of
chromatin modifying and remodeling enzymes. Towards this goal, we propose to integrate chemical probing
assays with high-resolution nuclear magnetic resonance (NMR) spectroscopy to obtain site-specific structural
and dynamic information about pioneer factor interaction with nucleosomes and the perturbations they elicit in
DNA and histones to potentially regulate other factors. In Aim 1, we will utilize in vitro binding assays to
characterize distinct binding modes of Sox2 and Oct4 to artificial and natural nucleosomes and their dependence
on DNA sequence, co-factor cooperativity, and histone composition. We will also adapt methyl TROSY NMR,
suitable for studies of super-large biomolecules, to interrogate the site-specific binding conformation and
dynamics of these proteins to select nucleosomes with atomic detail. In Aim 2, we will examine the effect of Sox2
and Oct4 binding in various nucleosome positions on the conformation and accessibility of nucleosomal DNA
and the disordered histone tails by using NMR, chemical and enzymatic probing methods sensitive to structural
and dynamic perturbations. We will further assess whether Sox2 and Oct4, through direct contact and
nucleosome perturbations, stimulate the activity of histone methyltransferase enzymes that are found to
collaborate in vivo with these pioneer factors. Finally, in Aim 3, we will adapt our approach to characterize how
a methyl-DNA binding protein and proposed pioneer factor Kaiso binds to and alters nucleosomes, providing
insight into the recognition and function of epigenetic DNA marks in chromatin regulation. The proposed work
will lay the basis for future investigations of other pioneer factors and the role of DNA context, synergistic action,
histone variants and epigenetic modifications into pioneer factor-mediated chromatin opening. This will improve
our ability to modify pioneer factor function and lead to novel approaches for therapeutic targeting.

Public health relevance
Project Narrative Pioneer transcription factors can bind and open silent chromatin, leading to transcriptional activation. The pioneer factors Sox2 and Oct4 orchestrate cell-fate changes during development, yet how they selectively target and destabilize closed chromatin remains largely unknown. This project will investigate the molecular details of how Sox2 and Oct4 alter the structure and epigenetic state of chromatin, which will advance our mechanistic understanding of pioneering action and ability to manipulate stem cells for research and disease therapy.